New Methods and Strategies for the Concise Synthesis of Complex Indole Alkaloids

PROJECT SUMMARY, ABSTRACT
The objective of this program is to develop broadly effective chemistry for the stereocontrolled chemical
synthesis of complex structures of use to chemists and medicinal chemists. The research plan is divided into
two Specific Aims, each opening access to distinct classes of natural products. Aim 1 describes the
development of an unexplored, dearomative-Claisen rearrangement, which allows functionalization of the C2
position of indoles, thereby enabling the stereocontrolled, asymmetric synthesis of 2,2-disubstituted indoline
derivatives. This new Claisen rearrangement transform will be incorporated into the design of efficient
strategies to indoline-containing natural products. Aim 2 presents the development of two [4+3]-cycloaddition
based routes for the synthesis of indole-fused cycloheptanes and the application of this chemistry to the
synthesis of the intricate and bioactive ambiguine natural products. The research plan is supported throughout
with compelling preliminary results, and the synthesis applications are designed to make maximal use of the
methodology, while addressing unmet synthetic challenges posed by the complex targets. The new chemistry
is expected to be broadly useful to organic and pharmaceutical chemists involved in drug development,
chemical synthesis, and natural product research. The final products of the total synthesis efforts and many
advanced intermediates will be submitted to a screening facility for biological testing. The proposed projects
will provide excellent training to graduate students and postdoctoral associates in chemical synthesis and
problem solving, preparing them for successful careers in the pharmaceutical industry and academia.

Public health relevance
PROJECT NARRATIVE This proposal outlines plans for the development of new methods and general strategies for chemical synthesis of complex, bioactive organic compounds. The results from this endeavor will produce new synthesis “tools” that will enable medicinal chemists in academia, government labs, and the pharmaceutical industry to more easily access intricate molecules that are needed for biomedical studies and for the development of pharmaceutical drugs. The challenging projects that will be examined will provide excellent problem-solving skills and training in synthetic organic chemistry for graduate students and postdoctoral associates and prepare them for careers in biomedical fields.